Modulation of Immune Defenses in Pathobiology of CNS Infection

Objectives: Cryptococcus neoformans is the most important fungal pathogen causing CNS-related mortality
and morbidity world-wide. Treatment of C. neoformans CNS infections is very challenging. There is increasing
evidence suggesting that paradoxical responses to therapy are mediated by patients’ own immune response to
the fungus supported by beneficial effects of anti-inflammatory therapy. However, the use of broad anti-
inflammatory (steroid) therapy is controversial because cryptococcosis is predominantly a disease of
immunocompromised population. Using model of CNS- crytptococcosis in mice we will investigate CNS
damage during cerebral cryptococcosis which we propose is a result of collaboration between myeloid cells with
the CNS recruited T-cells. Our studies will define the mechanisms by which these cells are recruited to the CNS
and cause detrimental CNS pathology. Hypothesis: CCR2-axis signaling recruits monocytes into the CNS,
which further promotes T-cells recruitment and polarization facilitating fatal CNS damage. We further propose
that Nitric oxide (NO) is central effector product of monocyte derived cells (MoC) activated by Th1 cells, which
induces CNS pathology. To test distinct parts of this hypothesis in our mouse model we will: Aim 1.
Determine whether CCR2-dependent MoC accumulation and activation drive CNS pathology. a) To establish
the how CCR2-axis affects the kinetics of MoC accumulation and activation in the CNS during CME; b) To
assess the contribution of the CCR2 axis/MoC to the development of CNS damage, neurological symptoms and
mortality during CME; c)To provide additional mechanistic proof of concept that CCR2+ monocytes induce
CNS injury in CME. Aim 2: Establish that CCR2+ MoC promote a Th1 response in the CNS during CME: a) To
determine whether MoC produce CXCR3 ligands and to assess whether T-cell recruitment into the CNS is
mediated via CXCR3-signaling; b) To determine whether CCR2+ MoC contribute to T-cell recruitment,
activation, and polarization; c) To assess whether the adoptive transfer Th1 cells from the infected CCR2+/+
mice into CCR2-/- mice restores CME-associated damage. Aim 3. Determine whether iNOS/NO from CCR2+
MoC is required to mediate pathological CNS tissue damage observed during CME: a) To specifically test
whether iNOS induction in CCR2+MoC mechanistically contribute to CNS pathology observed in CME; b) To
determine whether IFNγ/IFNγR signaling in CCR2+ MoC is required to induce iNOS in these cells and the
effect of IFNγ/IFNγR signaling on subsequent CNS damage.
Research Plan and Methods: This proposal will utilize our novel mouse model of CM, which accurately
recapitulates severe paradoxical immune responses experienced by patients with C. neoformans CNS infection.
We have previously shown that ultra-polarized IFNγ-producing CD4+ T cells accumulate in the CNS and
contribute to CNS pathology and mortality. In proposed work, we will use our in vivo model of C. neoformans
CNS infection along with in genetically modified mice to test specific aspects of our hypothesis, in vitro T cell
co-cultures, while in vivo adoptive cell transfers will help us to define the types of CNS tissue injury and the
role of CCR2+ and myeloid cells and other subsets of myeloid cells in CNS immune pathology. Specifically,
these strategies will use genetically deficient mice, including those lacking CCR2 (CCR2-/- - receptor
selectively removed from CCR2+ cells (CCR2γR-/-), CXCR3-signaling (CXCR3-/-), and mice unabel to make
nitric oxide globally (iNOS-/-) or only in CCR2+ cells CCR2-NOS-/-). The outcomes of our experiment
manipulations will be measured by a) analysis of fungal burdens b) analysis of neurological symptoms and
mortality c) flow cytometric analysis of infiltrating immune cells, d) analysis of mononuclear phagocyte
polarization profile and effector functions, e) gene expression analysis and f) histology. Overall, these studies
will provide significant insight on T cell mediated pathology during fungal CNS infections and are likely to
identify new biomarkers or therapeutic opportunities.

Public health relevance
Cryptococcus is a ubiquitous inhaled fungal pathogen which causes substantial morbidity and mortality in Veterans and other patients worldwide. Veterans have increased risk of infection due to higher rates of immunocompromising medical conditions relative to the general population (HIV and use of immune suppressive therapies). Current therapies for patients infected with Cryptococcus are lengthy, highly toxic, often ineffective, and may actually contribute to inflammatory complications. These complications are linked to pathological tissue damage, mortality, and/or development of lasting disabilities in these patients. This proposal will define the immune mechanisms underlying detrimental immune responses during cryptococcal CNS infection using an experimental model; our broader objective is to identify therapies we can use to treat Veterans suffering from CME. Our results will be also relevant to other CNS infections caused by pathogens to which Veterans are exposed to during deployment (malaria, tuberculosis meningitis and CNS viruses).